Defining Heterogeneous Human Mast Cell Effector Function

Project Summary/Abstract:
Mast cells (MCs) expand within the epithelium and sub-epithelium during prevalent and burdensome human
mucosal disease, including asthma, nasal polyposis, food allergy and eosinophilic esophagitis, where they are
thought to play a central role in disease pathobiology. MCs take on discrete protease expression profiles in
each location, with sup-epithelial MCs co-expressing tryptase and chymase (MCTC) while epithelial MCs
express tryptase alone (MCT). Although MCT preferentially expand during human type 2 mucosal inflammatory
disease, very little is known about how these cells influence tissue inflammation in part because all existing
systems for in vitro study of MCs give rise to MCTC. We have recently developed a novel cell culture system for
directing the selective in vitro differentiation of MCT or MCTC from human peripheral blood CD34+ cells,
allowing in-depth study of MCT effector function of phenotypes for the first time. This proposal seeks to use our
culture system to test the central hypothesis that MCTs within the epithelium have a discrete effector phenotype
and that a more comprehensive understanding of the effector function linked to this phenotype will enhance
our understanding of disease endotypes in nasal polyposis. A related hypothesis is that in vitro activation
profiles of MCTC poorly predict. In support of these hypotheses, preliminary findings indicate that in MCT and
MCTC have differential capacity to generate the pro-inflammatory eicosanoids and type 2 inflammation-linked
cytokines IL-5 and IL-13 following activation, mimicking transcriptional differences between the two phenotypes
in vivo, and that IL-4 differentially regulates upregulation of the high affinity IgE receptor FceR1a in each
population. Aim 1 of this proposal seeks to comprehensively define production of cytokines, chemokines and
growth factors in vitro-derived MCT vs MCTC in response to a range of activating stimuli, as well as determine
the transcriptional changes associated with each. Aim 2 characterizes the differential effects of several
inflammation-associated mediators on MCT vs MCTC activation, based on differential expression of cell surface
receptors and signal transduction components between the two subsets. Aim 3 datasets generated through
aim 1 and 2 to probe existing scRNA-seq data and datasets generated by a collaborator assessing
eicosanoids in the nasal lavage of nasal polyposis patients at baseline and following a series of therapeutic
interventions, in an attempt to use our in vitro findings to better understand MC effector function in vivo.
Completion of these aims will greatly expand our understanding MC effector capacity differential effector
capacity of human MC subsets in human disease and is a critical first step towards a more comprehensive
understanding of the role of MCs in human disease pathobiology.

Public health relevance
Project Narrative: Mast cells (MC) are potent inflammatory cells that accumulate within airway and digestive mucosal tissues during type 2 inflammatory diseases, including asthma, nasal polyposis, food allergy, and eosinophilic esophagitis, where they take on discrete intraepithelial and parenchymal phenotypes based on their tissue microenvironment. While each population is known to carry a discrete protease phenotype, the degree to which these populations differentially contribute to tissue inflammation is poorly understood. We have developed a novel cell culture system allowing the differentiation of both phenotypes from human peripheral blood progenitors, allowing direct comparison of the effector function of these two phenotypes. Using these systems, we have discrete cytokine and pro-inflammatory eicosanoid production profiles from the two phenotypes in response to activation and find that they both differentially respond to stimulus with type 2 inflammation-associated cytokines, all of which reflect the in vivo transcriptomic phenotype of intraepithelial versus parenchymal mast cells within human nasal polyps. This proposal seeks to comprehensively characterize the effector function of both subsites as a first step in understanding their relative contribution to human disease in vivo.